Fungal Translocation in Chronic Obstructive Pulmonary Disease

PROJECT SUMMARY
Although smoking is a leading risk factor for chronic obstructive pulmonary disease (COPD), other factors likely
contribute to disease pathogenesis since only a subset of smokers develop COPD. Tissue hypoxia related to
acute exacerbations or physical activity impairs gut epithelial barrier function in COPD and may result in microbial
translocation, or movement of microbes or microbial products across the intestinal mucosa. Once in circulation,
these microbial products may cause immune cell activation or direct lung injury, augmenting inflammation and
lung function decline in patients with COPD. Although studies of microbial translocation have largely focused on
the translocation of bacteria, we have preliminary data suggesting that fungal translocation occurs in smokers
and may contribute to COPD pathogenesis. We show that 1,3 beta-d-glucan (BDG), a pattern associated
molecular pattern that is a major polysaccharide component of the fungal cell wall, is elevated in COPD patients
in the absence of invasive fungal infection and correlates with lung function, symptoms, and exacerbations. In
vitro, BDG increases lung epithelial cell expression of inflammatory cytokines involved in the pathogenesis of
COPD. With this project, we will test the overarching hypothesis that impaired gut epithelial barrier integrity in
COPD patients leads to fungal microbial translocation that contributes to lung function decline and worse
respiratory morbidity through heightened immune cell activation and direct lung pathogenic effects. Aim 1 will
assess the relationship between gut epithelial barrier integrity measured by the lactulose/mannitol differential
sugar absorption test, lung function, respiratory morbidity (symptoms, exacerbations), and circulating BDG levels
in a cohort of current and former smokers with COPD. Aim 2 will determine the association between circulating
BDG levels, immune cell activation, prospective exacerbations, and two-year change in lung function, symptoms,
and CT indices of emphysema and airways in COPD. Aim 3 will determine whether BDG increases cytokine
expression and secreted protein levels by binding to the lung epithelial cell pattern recognition receptors Dectin-
1 and EphA2 in human bronchial epithelial cells in vitro, and if this effect is potentiated by co-exposure to cigarette
smoke. Aim 3 will also investigate if BDG effects on cytokine expression and secreted protein levels are
attenuated by treatment with metformin. At the completion of this project, we will have gained critical insight into
the role of microbial translocation in COPD pathogenesis and will have built the foundation for future clinical trials
targeting the gut-lung axis by either improving gut epithelial barrier function, blocking BDG’s actions, or
modulating BDG’s downstream effects as a novel approach to therapy in COPD.

Public health relevance
PROJECT NARRATIVE This project aims to understand how increased gut permeability and translocation of fungal products from the gut impacts lung function, respiratory symptoms, and disease progression in patients with chronic obstructive pulmonary disease (COPD). This project will also explore if the fungal cell wall product, 1,3 beta-d-glucan, has direct pathogenic effects on the lung and can be targeted as a novel therapy for COPD.